Development and application of whole-body patient-specific computational mesh phantoms for organ dosimetry and second primary cancer risk quantification following external beam radiotherapy

PROJECT SUMMARY
Approximately half of all cancer patients in the United States are treated with external beam radiotherapy (RT),
with approximately 40% of all curative treatment being attributed to it. Modern treatment planning systems (TPS)
are designed to optimize the target dose distribution such that the dose to the tumor volume is maximized and
doses to surrounding organs at risk are minimized. While this approach is successful in reducing the severity of
deterministic organ toxicities, there is mounting evidence to suggest that stochastic, radiation-induced second
primary cancer (SPC) risks are a serious concern following RT treatment and should be considered in TPS dose
engines. This is presently impractical due to the limited anatomical information present in the patient’s planning
computed tomography (CT) image studies. Furthermore, TPS that do compute doses to near- and out-of-field
organs either grossly underestimate their magnitudes or neglect to compute them entirely. A whole-body
computational phantom, with anthropometric parameters based on the patient’s demographic, could supplement
the limited geometric information present in the planning image. Implementing this model into a system-specific
Monte Carlo radiation transport simulation would then provide a practical means to compute doses to organs
distal to the treatment field with a high degree of accuracy. Previous work at the University of Florida has
produced the largest adult and pediatric computational phantom libraries to date, representing individuals of both
biological sexes over a wide range of heights, weights, and ages. Given this information, I hypothesize that
computational phantoms produced by merging CT planning images with patient-matched tetrahedral mesh-type
phantoms can be used to compute accurate near- and out-of-field organ doses and concomitant SPC risks
following RT, with potential for clinical implementation, medical record supplementation, prospective TPS dose
optimization, and future epidemiological studies. The proposed project will achieve this through the completion
of the following Specific Aims: Aim 1: Develop a system for generation of whole-body patient-specific mesh
phantoms from radiation therapy treatment planning CT images. Aim 2: Construct Monte Carlo radiation
transport source terms for external beam radiotherapy systems and assess normal organ doses and concomitant
SPC risks following radiotherapy treatment. The development of this system will fulfill an urgent need for RT
dosimetry methods which compute dose and SPC risk for all organs in the body post-treatment.

Public health relevance
PROJECT NARRATIVE External beam radiotherapy is an effective and widely used approach for the curative treatment of cancer. Increasing epidemiological evidence suggests that radiation-induced second primary cancers are a significant risk following radiotherapy, and therefore should be considered in the treatment planning and dose optimization processes for both near- and out-of-field organs. The proposed study will develop an end-to-end system for patient-specific dosimetry and cancer risk quantification for all normal organs following radiotherapy, with a focus on children and young adults.